Comparative analysis of photoreceptor developmental mechanisms in retinal organoids

Project Summary: Photoreceptor (PR) subtype patterning in the retina generates primate-specific
trichromatic color and high-acuity spatial vision. Networks of factors drive cells along poorly understood
developmental trajectories to reach terminal PR fates. Misspecification of PRs results in diseases causing
blindness. My central goal is to determine the mechanisms that specify PRs and how these change to
generate PR diversity among primates.
PRs express light-sensitive proteins called opsins, which confer distinct functions. Short-wavelength
sensitive cones (S cones) express S-opsin, long/medium-wavelength sensitive cones (L/M cones) express
L/M-opsin, and dim light sensitive rods express Rhodopsin (Rho). In humans, opsin expression follows a
temporal order: S opsin, then L/M opsin, and lastly Rho. The Johnston Lab found that retinoic acid (RA) and
thyroid hormone (TH) signaling specify cone subtypes in human retinal organoids. Early, low TH and high
RA signaling specify S cones. Later, high TH and low RA yields L/M cones. The mechanism by which TH
and RA signaling regulate PR development is unclear.
Comparative developmental biology is a powerful approach for revealing general mechanisms of
development and how tweaking these mechanisms generates diversity between species. In contrast to
humans, the initiation of opsin expression in the marmoset is inverted: Rho, then L/M opsin, followed by S
opsin, suggesting that marmoset PR subtypes are born in a different order and/or mature at different rates
compared to human PRs. I developed primate retinal organoid technology and determined that opsin
expression in organoids recapitulates species-specific developmental patterns. I will genetically and
pharmacologically manipulate retinal organoids to compare mechanisms of PR specification between
primates and identify changes that diversify retinal patterning between species.
During the K99 phase, I will determine how TH and RA regulate PR subtype specification and
maturation in human and marmoset organoids. During the R00 phase, I will elucidate how TH and RA
signaling regulates the cell fate trajectories of human and marmoset PRs during development. I will identify
and validate candidate cis-regulatory changes that drive differences in PR specification, by knocking out
associated genes, reciprocally swapping putative divergent regulatory elements in stem cells, and assessing
effects in human and marmoset organoids. These comparative approaches will untangle the regulatory
networks underlying the divergence of PR development between primate species.
My goal is to become a leader in the field of neuronal fate specification, with a focus on understanding
mechanisms of cell fate determination in primate retinal development. My mentoring team and the Johns
Hopkins University community will provide the ideal environment for achieving in this goal.

Public health relevance
Project Narrative: The proportions and patterning of photoreceptor subtypes in the retina generate many primate-specific features of vision, including trichromatic color vision and high-acuity spatial vision. Disruption of photoreceptor specification results in disorders causing blindness. To unravel the temporal signaling mechanisms that specify primate photoreceptors, I will compare development in human and marmoset retinal organoids, "mini retinas" grown from primate stem cells.